Neuroimaging Core

The Neuroimaging Core (Imaging Core) of the Massachusetts Alzheimer’s Disease Research Center
(MADRC) provides state-of-the-art neuroimaging expertise for the MADRC and affiliated research studies,
for collaborative efforts with other ADRCs, and for national ADRD research initiatives. The Imaging Core
brings together a multidisciplinary group of investigators and a rich array of resources to better understand
the drivers of clinical progression of Alzheimer’s Disease and Related Disorders (ADRD). We will acquire,
analyze, and share MRI scans on all Research Cohort participants every other year and will obtain, process,
and distribute longitudinal amyloid and tau PET scans and an enhanced MRI protocol on an Intensive
Imaging Subgroup (in response to the RFA mandated imaging datasets). We will promote the exchange of
expertise and collaboration to make optimal use of participant involvement and scan data, and to support
MADRC-affiliated research. This will catalyze the pooling of local resources and imaging datasets,
supporting emergent scientific discovery through collaborative analyses beyond those funded by individual
grants. In addition, MADRC Imaging Core personnel work closely with national and international research
efforts in and beyond the ADRCs to optimize neuroimaging biomarkers for use in ADRD research and trials
as we enter an era of disease-modifying therapies.
The Imaging Core will play a major role in helping MADRC achieve its overarching goal of
understanding drivers of clinical progression. The Core aims to contribute MRI and PET data and
analytic and interpretive expertise to local, regional, national, and international ADRD research (Aim 1). The
Core will develop, implement, and share new MRI and PET imaging methods and data to better understand
inter-individual variability in the pace of change. We will utilize imaging data from MADRC-funded and
affiliated studies as well as uniformly collected imaging data from clinical assessments to better understand
how new treatment modalities affect clinical progression and impact research (Aim 2). We will train clinical
and translational researchers from diverse backgrounds in imaging methods and support imaging
clinicians/scientists in conducting ADRD imaging research by collaborating with the Research Education
Component (REC) (Aim 3). The Core aims to diversify Research Cohort and other ADRD imaging research
participants as well as staff by working with the ORE Core and other cores in outreach and educational
efforts (Aim 4). We will freely disseminate our methodological innovations to the scientific community and
promote open and reproducible science through imaging data and acquisition and analytic methods sharing.